Technology Enabled Research Resource Core 3

PROJECT SUMMARY/ABSTRACT (TER-RC3)
The new Technology-Enabled Research Resource Core (TER-RC3) will support the UTMB OAIC in enhancing
aging research by integrating technology that helps individuals with disabilities and other health disparities
maintain independence and aids researchers in collecting accurate functional data. By prioritizing usability, the
TER-RC3 ensures that older adults can easily engage with technology for interventions and data collection,
which is vital for improving study fidelity. The Core will maintain a warehouse of wearable sensors
(WEARHouse) and assessment laboratories, provide education and expertise in technology implementation in
research, and refine technology through iterative usability testing with a Community Usability Board (CUB)
through the following aims:
Aim 1. Support the use of innovative technology in aging research studies.
Aim 2. Provide education, training, and outreach for technology-enabled research.
Aim 3. Assess the usability of technology and provide support for technology adaptation to address
health disparities.
The UTMB OAIC has extensive experience in using technology in aging research and adapting technology for
specific functional needs. Reflecting national trends, there has been a significant increase in the use of and
demand for technology in aging research at UTMB. Both investigators and their older participants may be
unfamiliar or uncomfortable with the rapidly evolving field of technology. Specific methods are needed to adapt
technology for use in older adults experiencing health disparities such as physical disability, language barriers,
gender differences, and low education.TER-RC3 will serve as the home for researchers from the UTMB OAIC
and partner institutions using technology in their research projects. Further, we will expand our resources to the
larger UTMB Health System and national OAIC network after year 2. In year 1, TER-RC3 will support
technology-enabled research in 9 External projects, 2 Pilot/exploratory studies, and with 1 Research Education
Component Pipeline Scholar. We will delay the start of developmental projects to year 2 to allow for the start-
up of this new core. The TER-RC3 is a central component of the innovation of the UTMB OAIC as it will
support aging research using novel technologies and novel technology-enabled study designs.